A Residential Dust Control Intervention to Reduce Early Childhood Exposure toChemical Mixtures

Abstract
Exposure to endocrine disrupting chemicals (EDCs) during critical periods of development are linked to
adverse child health outcomes, including asthma/allergies, behavior problems, IQ decrements, and obesity.
Phthalates, flame retardants, and perfluoroalkyl substances (PFAS) are EDCs found in residential dust due to
their use in home furnishings, building materials, electronics, and personal care products. Children are
exposed to these EDCs as a mixture over the first years of life, often at higher levels than adults. Despite
growing consensus that EDC exposures must be reduced, we lack effective interventions to decrease
children’s exposure to EDC mixtures in their homes, where they spend the majority of their time. Thus, it is
imperative to quantify the contribution of EDC mixtures in residential dust to children’s EDC mixture body
burden and determine if interventions that reduce residential dust EDC mixtures effectively diminish childhood
exposure to EDC mixtures. We will address this gap in knowledge using data from the Health Outcomes and
Measures of the Environment (HOME) Study, a previously conducted randomized controlled trial that enrolled
pregnant women from Cincinnati, Ohio and followed their children until age 3 years. We repeatedly collected
biospecimens, residential dust samples, and other data from ~200 children ages 1 to 3 years. Using these
existing data, we will: (1) Estimate the extent that exposure to EDC mixtures in residential dust is related to
children’s EDC mixture body burden; (2) Determine if an intervention designed to reduce residential dust can
lower children’s EDC mixture body burden; and (3) Quantify the extent that EDC mixtures in residential dust
mediate the relation between an intervention designed to lower residential dust and children’s EDC mixture
body burden. Moreover, we will determine if these associations differ by child sex, race/ethnicity, hand-to-
mouth behavior, residence type (single vs. multi-family), and residential cleanliness. This solutions-oriented
proposal includes experts in EDCs, epidemiology, biostatistics, intervention studies, and children’s
environmental health. Together, we will efficiently determine if residential dust control can decrease children’s
exposure to EDC mixtures. These results will serve as a basis to design a randomized controlled trial to reduce
exposure to EDC mixtures using an ongoing cohort study in Rhode Island. In the absence of population-level
interventions to mitigate children’s EDC exposure, our study may provide families and clinicians with evidence-
based recommendations about the efficacy of residential dust control to reduce exposure EDC mixtures.

Public health relevance
Narrative There are few effective interventions to reduce childhood exposure to endocrine disrupting chemicals (EDCs), which may negatively impact the health and wellbeing of children. This study will determine if household dust is a major pathway of exposure to mixtures of endocrine disrupting chemicals and if dust control can reduce exposure to EDCs. The results of this study will guide future intervention studies and provide parents and clinicians with recommendations to reduce childhood exposure to EDCs.